The impact of progranulin species on TDP-43 proteolysis and pathobiology

Neurodegenerative disorders such as Alzheimer’s Disease (AD), frontotemporal dementia (FTD) and
limbic-predominant, age-associated TDP-43 encephalopathy (LATE), are age-associated diseases
characterized by aberrant protein homeostasis. Lysosomes and the lysosome-dependent autophagic
processes degrade and recycle macromolecules, thereby promoting cellular protein homeostasis and
preventing inclusion formation. Proteolysis in the lysosome is carried out by a suite of proteases, known
as cathepsins, that each recognize specific linear amino acid sequences. Declines in lysosomal
function with age have been shown to contribute to neurodegenerative disease pathogenesis and
genetic evidence also strongly supports the importance of lysosomes in AD, FTD and LATE. For
example, loss-of-function mutations in the Pgrn gene lead to protein haploinsufficiency and FTD with
TDP-43 aggregates. PGRN is a lysosome-resident protein that can be cleaved first into bioactive multi-
granulin fragments (MGFs) and then individual granulins (henceforth collectively referred to as PGRN
species). We have demonstrated that 1) relative levels of PGRN species change with age, 2) PGRN
and MGFs promote the activity of a key lysosomal protease, CTSD, while 3) granulins inhibit cathepsin
activity and TDP-43 clearance. Still unclear are precisely how PGRN species alter TDP-43 cleavage
and why these processes change with age and Pgrn haploinsufficiency. The major focus of my
research group is to utilize multi-disciplinary approaches to understand how lysosomes contribute to
aberrant proteostasis in aging and neurodegeneration. Our objective here is to determine how PGRN
species contribute to TDP-43 accumulation with age and Pgrn haploinsufficiency. Our central
hypothesis is that age and Pgrn haploinsufficiency alter the relative levels of intact vs cleaved PGRN
species, thereby impacting the ability of lysosomal proteases to degrade TDP-43. The rationale for this
work is that if TDP-43 is not efficiently degraded, steady-state levels will increase, promoting TDP-43
aggregation and potentially contributing to selective vulnerability to TDP-based diseases. To address
our hypothesis, we propose the following specific aims. Aim 1: Test the ability of PGRN species to
modulate TDP-43 proteolysis in vitro. Aim 2: Define the capacity of induced neurons, astrocytes
and microglia with and without Pgrn deficiency to degrade and clear TDP-43. Aim 3: Determine
how PGRN species and proteolysis of TDP-43 changes with age and PGRN deficiency in murine
models. Successful completion of the proposed aims will enhance understanding of the factors
governing TDP-43 proteolysis with age and disease. This information could reveal new therapeutic
avenues for treating TDP-43 diseases and has implications for precision medicine in other forms of
neurodegeneration.

Public health relevance
The proposed research is relevant to public health because, as our population ages, the financial and societal burden of neurodegenerative diseases will greatly expand over the coming decades. This proposal seeks to understand the pathobiology of Alzheimer’s Disease (AD), frontotemporal dementia (FTD) and limbic-predominant, age-associated TDP-43 encephalopathy (LATE), which will have several positive impacts, including understanding the potential negative consequences of progranulin replacement strategies and identification of novel targets for drug therapy. The proposed research is relevant to the NIH’s mission of extending healthy life and reducing the burdens of illnesses like AD, FTD and LATE.